Hopkins Economics of Alzheimer's Disease and Services (HEADS) Center

Abstract – Overall
This application requests funding to establish the Hopkins’ Economics of Alzheimer’s Disease & Services
(HEADS) Center. The Center’s overall goal is to advance population-based science that addresses ADRD
care and its economic consequences. We will meet this goal through research that addresses two themes: (1)
Identifying and quantifying the range of ADRD care needs and related economic consequences and (2)
Examining how the organization, financing, and delivery of services affects accessibility, affordability, quality,
and equity of ADRD care. Within each theme, HEADS Center research will emphasize family and unpaid
caregiving and disparities. We meet our overall goal and address Center themes through two Specific Aims.
SPECIFIC AIM 1 is to generate new knowledge concerning ADRD care in the areas of the HEADS Center's
thematic focus. SPECIFIC AIM 2 is to advance the field of ADRD economics and health services research
and its impact by nurturing emerging and established investigators, developing a cutting-edge research
infrastructure, disseminating new knowledge, and forging linkages with policy and practice communities. The
HEADS Center will accomplish its Aims through an infrastructure of four Cores. Core A, the Administrative
and Research Support Core will develop and execute the Center’s strategic vision by coordinating and
managing research, methods, data, community-building, and dissemination resources across Cores. Core B,
the Program Development Core will provide funding, interdisciplinary research mentorship, and regulatory
monitoring for novel pilot studies that can advance research within our themes, develop the careers of
researchers addressing these themes, and attract investigators to the field. Core D, the External Research
Resources Support and Dissemination Core, will build the community of scientists engaged in research
related to HEADS themes, facilitate rigorous use of research resources, disseminate scientific evidence
developed within our themes, and nurture partnerships with key stakeholders and advocacy organizations to
translate findings into policy and practice. Core E, the Remote Data Enclave Core will create and sustain a
high-capacity, secure computing environment, that can generate new investigations and investigators
pursuing projects within our themes that leverage unique linkages between ADRD related data, many with
strict security requirements. The HEADS Center will leverage unique strengths at Johns Hopkins University
(Hopkins) to build a cross-school, interdisciplinary, and diverse environment for developing and executing
innovative research to advance population-based science that addresses ADRD care and its economic
consequences.

Public health relevance
PUBLIC HEALTH RELEVANCE Nearly 6 million Americans are living with Alzheimer’s Disease and Related Dementias (ADRD). The Hopkins’ Economics of Alzheimer’s Disease & Services (HEADS) Center draws on unique strengths at Johns Hopkins University (Hopkins) to advance population-based science relating to ADRD care and its consequences. The Center builds the field of ADRD-related economics and health services research and its impact through training emerging and established investigators, developing research infrastructure, and forging linkages with policy and practice communities to disseminate new knowledge.